Administrative and Protocol Management Core

The Administrative and Protocol Management Core (Core A) of this grant will provide administrative support for the four scientific projects and two scientific cores for the program entitled, Alternative Formulations of Tenofovir and UC781. Specifically, the Administrative Core will 1) provide administrative oversight of the scientific projects and cores in this program, 2) provide fiscal oversight and coordination for the program across all projects and cores, 3) be the primary point of contact between this research program and the NIAID Program Officer in charge of the Integrated Preclinical/Clinical Program for HIV Topical Microbicides, 4) plan and coordinate monthly conference calls for the Scientific Steering Committee, 5) establish a Scientific Advisory Panel of outside scientists to attend an annual meeting of the Scientific Steering Committee and NIAID program scientists, and 6) assist Core C with coordination of research activities with corporate partners and CONRAD. In addition, this Core will provide protocol management support for the clinical studies in Projects 3 and 4, and ensure smooth interactions between CONRAD, which holds the proprietary rights to UC781 and tenofovir, the University of Pittsburgh IRB, and the Division of AIDS. This Core, which will be led by Drs. Sharon Hillier and Lisa Rohan, will support all four scientific projects and both scientific cores through the promotion of scientific interactions and collaborations with other investigators engaged in microbicide research.

Public health relevance
The Administrative and Protocol Management Core will provide administrative, regulatory and fiscal support for the scientific projects which will support the development of film formulation of UC781 and tenofovir as topical microbicides